4/4 Adapting Treatments for Suicidal College Students: A Multisite Trial

Project Summary
Suicide is the 2nd leading cause of death among college students and suicidal ideation and suicide-related
behaviors are a frequent presenting problem at college counseling centers (CCCs), which are overburdened.
Studies show that some students respond rapidly to treatment, whereas others require considerably more
resources. Evidence-based adaptive treatment strategies (ATSs) are needed to address this heterogeneity in
responsivity and complexity. ATSs individualize treatment via decision rules specifying how the type and
intensity of an intervention can be sequenced based on risk factors, response, or compliance. We are
proposing a multisite study to investigate ATSs through a SMART (sequential, multiple assignment,
randomized trial) to address suicidal risk in treatment-seeking college students. This multisite study (University
of Nevada, Reno; Duke University, University of Oregon; Rutgers University), submitted in response to RFA-
MH-18-700, Collaborative R01s for Clinical Trials, will enroll moderately to severely suicidal college students in
the “emerging adulthood” phase (ages 18-25) seeking services at CCCs. This SMART will have two stages of
intervention. In the first stage, 700 participants from four CCCs will be randomized to 4-8 weeks of: 1) a
suicide-focused treatment – Collaborative Assessment and Management of Suicidality (CAMS) or 2) Treatment
as Usual (TAU). Sufficient responders to either intervention will discontinue services/be stepped down. Non-
responders will be re-randomized to one of two second-stage higher intensity/dosage intervention options for
an additional 4-16 weeks: 1) CAMS (either continued or administered for the first time) or 2) Comprehensive
Dialectical Behavior Therapy (DBT), which includes individual therapy, skills groups, and phone/text coaching
for the clients and peer consultation for the therapists. The aims of this research project are to 1) compare the
efficacy of the four ATSs in reducing students’ suicidal ideation, non-suicidal self-injury, and suicide attempts;
2) evaluate whether, as hypothesized, a sequence that starts with a suicide-focused treatment approach (i.e.,
CAMS) is more effective in reducing suicidal risk than TAU; 3) determine whether, as hypothesized, a more
comprehensive, suicide-focused approach (i.e., DBT) is more helpful as a second stage intervention for
insufficient responders, relative to a less intensive suicide-focused approach (i.e., CAMS); 4) assess the
mechanisms of change leading to reduced suicidal risk for each treatment; specifically, to evaluate suicidal
cognitions as a mediator in CAMS and emotion regulation-based processes and use of skills as mediators in
DBT; 5) examine baseline factors as predictors and/or moderators of treatment outcome; 6) evaluate the
dissemination potential and cost effectiveness of using these ATSs within a CCC setting. This study will
provide essential guidance to CCCs on how to best allocate limited resources to alleviate an increasing public
health crisis.

Public health relevance
Project Narrative This multisite study will test an adaptive intervention strategy for college students who are suicidal when seeking treatment at a college counseling center. At this time, the typical strategy relies on a “one-size-fits-all” approach, but in fact suicidal college students vary greatly on what and how much they need. This study will allow clinical decision making (trying one approach, and if that doesn’t work, another) to be empirically tested while maximizing resources in overburdened college counseling centers.